Nucleus-to-cytoplasm trafficking of chromatin fragments in senescence and aging

PROJECT SUMMARY
Cellular senescence is a stable form of cell cycle arrest program associated with pro-inflammatory responses.
Senescent cells accumulate in diseased and aged tissues, where they impair tissue renewal and promote
inflammation. Clearance of senescent cells using genetic or pharmacological tools ameliorates disease severity
and promotes healthy aging. Therefore, understanding the biology of senescence is an important biomedical
objective.
The inflammatory program of senescence is a major contributor to the detrimental roles of senescence in aging
and disease. Senescent cells secrete a large array of inflammatory cytokines, chemokines, proteases, and
growth factors, collectively termed senescence-associated secretory phenotype (SASP). The SASP program
recruits immune cells, modulates tissue microenvironment, and ultimately causes inflammation that contributes
to most, if not all, age-associated pathologies. Hence, understanding and targeting the SASP program is a major
direction in senescence and aging research.
Our group contributed to our understanding of the mechanisms of the SASP by showing that the cytosolic DNA
sensing cGAS-STING pathway is involved. In senescent cells and aged mouse tissues, chromatin fragments
undergo nucleus-to-cytoplasm trafficking, via nuclear membrane blebs that bud off the nuclei, forming
cytoplasmic chromatin fragments (CCF). CCF activates cGAS and the SASP program. These results have been
independently reproduced by other groups and collectively the CCF-cGAS-STING pathway is considered as one
of the central mechanisms that contribute to the SASP program.
CCF, by microscopy measurements, is a large entity with an average size of 2 um, which is significantly larger
than the capacity of the nuclear pore complex with an upper limit of approximately 100 nm. A key unaddressed
question is the mechanism that shuttles the CCF from the nucleus to the cytoplasm. This study investigates a
central hypothesis that CCF is shuttled to the cytoplasm via a membrane-trafficking mechanism that
resembles viral nuclear egress. First, we propose to investigate the proteins at the inner and outer nuclear
membrane that mediate the nuclear egress of CCF and the consequence of the SASP program using senescent
cells in vitro. Second, we aim to evaluate the importance of nuclear egress complexes in mediating CCF and the
SASP in mouse models of senescence. Third, because aging and inflammation are closely connected with
nutrient metabolism, we will further investigate the impact of metabolic alterations on nuclear egress of CCF,
focusing on the stability of proteins involved in nuclear egress.
This study will provide novel mechanistic insights into the formation of CCF, a key event that triggers the SASP
program. This knowledge may facilitate the development of new therapies that target the cytosolic DNA sensing
pathway to intervene in aging and age-associated diseases.

Public health relevance
PROJECT NARRATIVE Chromatin, a nuclear entity in a cell, can be abnormally shuttled to the cytoplasm during aging, leading to inflammation. This proposal studies how fragments of chromatin are shuttled from the nucleus to the cytoplasm, and how to block this pro-inflammatory process via metabolic changes. This study will offer novel insights into age-associated inflammation, with potential to develop new strategies to suppress chronic inflammation and to promote healthy aging.